The Contribution of Age-Related Taupahtoies to Alzheimer's Disease-Supplement

Establishing an accurate neuropathological diagnosis is a critical function of Alzheimer’s Disease Research
Center (ADRC) Neuropathology Cores and is a prerequisite for all tissue-based research. Chronic traumatic
encephalopathy (CTE), primary age-related tauopathy (PART), argyrophilic grain disease (AGD) and aging-
related tau astrogliopathy (ARTAG) are all age-related tauopathies, yet each has distinctive patterns of abnormal
tau deposition. Criteria to diagnose CTE, PART, AGD and ARTAG have been recently proposed, yet no modules
exist to capture these disorders in the National Alzheimer’s Disease Coordinating Center (NACC) database.
Without rigorous, reproducible protocols for the diagnosis of age-related tauopathies, disease-specific
contributors to late life cognitive decline might be overlooked, confused, and obscured. Twenty-nine Alzheimer
Disease Research Centers across the U.S. contribute neuropathological data to the National Alzheimer's
Coordinating Center - Neuropathology Data Set (NACC-NDS), making the NACC-NDS one of the largest publicly
accessible neuropathological datasets on AD and related disorders in the world. In this proposal we will draw on
the neuropathological expertise of Dr. Ann McKee, Dr. Dennis Dickson, and Dr. John Crary, who have pioneered
investigations of CTE, AGD and PART. We will use 152 cases of AD and age-related tauopathies from the
Boston University, Mayo Clinic Jacksonville, and Mount Sinai ADCs to identiify novel tau and inflammatory
markers to detect and distinguish the disorders. We will also establish the frequency of CTE, PART, AGD and
ARTAG among 600 cognitively normal, mild cognitively impaired and demented subjects in the NACC-NDS with
NACC-Uniform Data Set (UDS) diagnosis and determine the contribution of these disorders to clinical diagnosis
and cognitive and neuropsychiatric profile. We will apply knowledge gained from this project to develop CTE,
PART, AGD and ARTAG assessment modules and provisional criteria to neuropathologically differentiate the
age-related tauopathies for general use. This proposal will answer a critically unmet need in the study of
neurodegeneration. Specifically, it will identify novel tau and neuroinflammatory markers in CTE, PART, AGD
and ARTAG to aid in their detection and discrimination. This project will also determine the frequency of these
age-related tauopathies among memory disorder clinic patients and determine whether these disorders
contribute to the clinical profile. In addition, this project will develop a digital library of immunostained slides from
600 NACC cases (200 normal cognition, 200 MCI, 200 dementia) with UDS phenotyping that will be available to
other ADRC and NACC investigators. This research has the potential to transform the way we conceptualize
MCI and dementia, and ultimately, develop more effective therapeutic strategies, by developing harmonized
criteria for the diagnosis of distinct disorders that contribute to the clinical diagnosis, cognitive and
neuropsychiatric profile, and neuropathological phenotype of memory disorders patients.

Public health relevance
Narrative Supplement The proposed research is relevant to public health because it will establish the contribution of the age-related tauopathies, including chronic traumatic encephalopathy (CTE), primary age-related tauopathy (PART), argyrophilic grain disease (AGD) and aging-related tau astrogliopathy (ARTAG) to late life cognitive decline and neuropsychiatric symptoms. This project is relevant to NIA’s mission of improving the health and well-being of older people because it will increase the accuracy of neuropathological diagnosis in mild cognitive impairment and dementia, which will facilitate future research on the diagnosis, treatment, and prevention of Alzheimer’s Disease and related disorders.